Administrative Core

ABSTRACT – ADMINISTRATIVE CORE
The highly integrated nature of the University of Michigan O'Brien Kidney Translational Core Center (MKTC)
requires a robust and active Administrative Core, which will coordinate workflow, distribution of resources and
operations assessment of the Biomedical Research Cores. The Core will continue to set goals and objectives
for the Center's operation and conduct ongoing review of the Center through consultation and survey of the
Center's membership, advice of Internal and External Advisory Committees and interactions with other
institutional P30 and external O'Brien Kidney Centers. In addition, the Administrative Core will organize,
stimulate and evaluate interactions of the Center with our Institutional and International Research Bases to
ensure that the Biomedical Research Cores and educational programs are providing optimal support. The
core will also reach out to new faculty and other potential research base members to continue expanding the
numbers in both bases. The core will also recruit new investigators to apply to the Pilot and Feasibility
Program and will continue to administer this very successful program using expert institutional and external
reviewers. The core will modify, update and request Center services. Maintaining a vibrant educational
environment for kidney research, especially in T1 translational research, continues to be a major goal and the
core will implement the effective Educational Enrichment Program including the Summer Students Research
Program. The Administration Core will oversee the resource expenditures of the MKTC and be responsible for
the reporting to internal and external stakeholders and to the NIH. The Core, through the Core's Working
Group, will oversee all Cores, Enrichment Programs and the Pilot and Feasibility Grant Programs, ensuring
that expenditure of cost-share funds are properly allocated to support investigators. The Core will also ensure
that agreements between the administrations of entities who have agreed to co-funding will be properly
executed and documented The Administration Core will maintain a Website for investigators and the public use
to interact and to promote MKTC activities. The core will continue to support an Annual Educational Retreat for
all research base investigators, including those at our other sites, to highlight translational research
approaches, review research progress and obtain feedback on Center services. Throughout all these
processes, the core will obtain quality assurance and improvement information from Research Base
investigators. The core will host an annual meeting of our Institutional Scientific Advisory Board and our
External Advisory Board to obtain advice on progress and new directions. The Administrative Core also hosts
the Core Discount Program, which largely supports our Institutional Research Base investigators by providing
discounts for a variety of institutional biomedical resource cores including transgenic, epigenomics,
sequencing, metabolomics, histology, and other research facilities.